PRIMATE MODEL OF ENDOMETRIOSIS

Objective To characterize the prevalence and causes of endometriosis in the aged female monkey, and to assess immune alterations associated with endometriosis. In the course of a study on the long-term effects of dioxin exposure, Drs. R. Bowman and S. Rier discovered that female monkeys exposed to either 5 or 25 ppt TCDD for 4 years were at greater risk for developing endometriosis as they aged (Rier et al., 1993, Fundamental and Applied Toxicology). 71% of females in the high dose group and 43% in the low dose developed endometriosis, in contrast to 33% of the control subjects. These females are now approximately 24 years of age, and provide a unique opportunity for assessing endocrine and immune sequelae associated with this chronic disease. We have been evaluating lymphocyte cytolytic responses and in vitro cytokine production in these subjects. In addition, we have been investigating the natural prevalence of the disorder throughout the colony by means of an in-depth analysis of necropsy records over the last 15 years. Recently, we have identified certain family lineages of monkeys at greater risk for this gynecologic condition. Future studies will focus on predictors of disease in offspring in these high- and low-risk families. Key words endometriosis, aging, inflammation, cytotoxic responses, female toxicology